Cell Identity and differentiation in stimulus response

Organs are composed of cells with distinct identities designed to interpret stimuli in specialized ways and coordinately fulfill complex functions. In order to understand how cells perform these specialized functions I plan to study the mechanisms by which cell identity alters the quality and quantity of a stimulus response. I propose to use Fluorescent Activated Cell Sorting (FACS) in combination with cell-type specific fluorescent marker lines to isolate individual cell types of the root after treatment with a stimulus. Using microarrays, I will then analyze the transcriptional changes that occur in each cell type of the root and identify genes that demonstrate cell-type specific transcriptional responses. These data will not only lead to a better understanding of the relationship between cell identity and stimulus perception and response but will also lead to the development of markers to monitor this regulation and marker-based mutant screens to identify the genetic mechanisms that control it. In addition, I propose to collaborate in the development of a high-throughput platform for visualizing root development and physiology termed the "root array" that will facilitate the work proposed here and contribute to the design of future experiments.